INTERLEUKIN 6 AS A MARKER FOR BONE LOSS IN PRIMARY HYPERPARATHYROIDISM

The purpose of this study is to prospectively examine the relationship between circulating levels of selected cytokines and rates of bone loss in patients with primary hyperparathyroidism.